Molecular mechanisms underlying microbial modulation of host behavior

A central question in behavioral biology is how environmental and genetic factors shape behavioral traits,
allowing for substantial individuality. Homeostatic behaviors like feeding and food preferences are prime
examples of genetic predispositions interacting with the food environment to produce diverse feeding habits.
However, these programs are further modified by host-associated microbes, suggesting the overall systems
controlling behavioral phenotype is far more complex than first anticipated. The critical questions that remain
to be addressed are: to what extent do host-microbe interactions contribute to individual differences in behavior?
Specifically, how does gene regulation of behavior operate in the context of host-microbe symbiosis? Implicit in
this question is the hypothesis that perturbation of host-microbe symbiosis results in aberrant behavioral
outcomes in certain individuals or populations, a topic fundamental to human health yet unsolved.
The goal of my research program is to define how behaviors are shaped by host-microbe interactions.
My lab studies foraging and food choice behaviors in the fly Drosophila melanogaster, using a gnotobiotic system
I developed that permits precise configuration of the fly microbiome. I hypothesize that feeding behavior and
food preferences are the product of host genetics-microbiome interactions, which determine, in part, an
individual’s long-term health. Our recent data show that foraging and diet selection preferences vary by the
microbiome, and altering the microbiome triggers transcriptional changes in specific cell clusters within the fly
brain, involving genes predicted to affect behavior. In this five-year plan, I will leverage fly genetics and state-
of-the-art genomics and metabolomics tools to identify the gene regulatory networks and mechanisms
underlying microbial modulation of host behavior. Expected outcomes include comprehensive gut endocrine
signaling and inter-organ communication maps at single-cell transcriptome scale and metabolite-gene
interactions networks. The causal effects of microbiome-responsive genes, neuropeptides, and metabolites on
host feeding behavior and food preferences will be revealed. Since we know little about how the interplay of
host genetics and microbiome contribute to complex behavior, my research has the potential to advance
fundamental knowledge in behavioral genetics but also to identify genes or processes that may function
similarly in Drosophila and mammals as targets to treat behavioral disorders, such as eating disorders and obesity.

Public health relevance
This project investigates the mechanisms underlying microbial modulation of behavior. We will integrate single-cell transcriptomics, metabolomics, Drosophila genetics, and quantitative behavioral assays to reveal to what extent and how host genetics-microbiome interactions shape feeding behavior and food preferences. The results will advance foundational knowledge of behavioral genetics and may yield molecular targets for developing treatments to combat diseases caused by behavioral disorders.